Regulation of pathogen sensing and inflammation by NLR proteins

Project Summary The NLR (nucleotide-binding domain, leucine-rich repeat containing protein, also known as NOD-like receptor) family is a diverse group of proteins that functions to regulate host immunity. Many of the NLRs have been shown to regulate inflammasome formation and control caspase-1 activation, IL-1β/IL-18 secretion and inflammatory cell death. In contrast a subset of NLR proteins negatively regulates different inflammatory pathways, typically via inhibitory interactions with key signaling molecules. Nonetheless the molecular mechanisms that control the negative regulation of inflammation are poorly understood. NLRC3 in particular has been shown to negatively regulate several key inflammatory pathways. For example, NLRC3 has been shown to inhibit NF-κB and PI3K pathways in response to TLR (or IGF-1R) signaling and proinflammatory cytokine secretion; alternatively, NLRC3 inhibits type I interferon production in response to cytosolic nucleic acid stimulation by regulating STING trafficking. The molecular mechanisms to allow for NLRC3 to function in diverse pathways are poorly understood. Understanding the molecular mechanisms of negative regulation of inflammation will be necessary for the generation of new strategies to improve health. Aim 1 of my proposal uses classic biochemical and cell biological techniques to examine the molecular determinants of novel protein-protein interactors with NLRC3. Our studies suggest that one of these interactors negatively regulates type I interferon production possibly by relocating NLRC3 to the cell cortex. I propose experiments to investigate how these interactions are mediated. In Aim 2 and 3 of my proposal, we will investigate the role of these protein-protein interactions using siRNA knockdown experiments and advanced microscopy to investigate the role of protein localization and trafficking in NLRC3- mediated inhibition of cellular pathways.

Public health relevance
Project Narrative The negative regulation of inflammation is necessary to prevent an overzealous response. Perturbations in the balance of an appropriate response, either too aggressive or attenuated, underlie immunopathology, transformation and chronic metabolic syndrome. Understanding the molecular mechanisms of negative regulation of inflammation will be necessary for the generation of new strategies to improve health.